NEDOCROMIL SODIUM ON AIRWAY INFLAMMATION AS MEASURED BY BRONCHOALVEOLAR LAVAGE

The purpose of this study is to determine the effect of nedocromil (an anti-inflammatory anti asthma agent) on the immunologic, bronchial, and pathologic features of the airway mucous and bronchoalveolar lavage fluids of asthmatics.